Anti-inflammatory Cell Based Repair of Intervertebral Disc Degeneration

Project Abstract
Discogenic back pain, is a leading cause of disability, and involves degenerative changes of the
intervertebral disc (IVD), including matrix degradation, altered cell shape and phenotype,
inflammation, and pathological nerve ingrowth. Since only a small subset of patients responds favorably to
conventional treatments which address the symptoms but not the disease, there is a need for new therapies to
treat disc degeneration (DD). Pro-inflammatory cytokines, which are associated with painful DD, lower the
threshold for pain and lead to an exaggerated pain response or increased pain sensitivity (hyperalgesia). In the
parent award, we are identifying strategies to reduce the pro-inflammatory and enhance the anti-inflammatory
responses of bone marrow derived MSCs treatment for IVD repair. Therefore, the goal of this project is to
examine ‘bidirectional interaction between injured painful IVD and sensory nerves’, an area of interest described
in NOT-AR-23-015. The goal of this project is to define the innervation and phenotype of the sensory neurons
innervating the caudal IVD, and to assess changes in the DRGs of the innervating neurons with injury and
mesenchymal stem cell (MSC) treatment. This project meets Goal A, to generate supporting evidence towards
a future innovative study and new scientific direction in pain research in musculoskeletal diseases. Aim S1
studies will spatially map the sensory neural innervation of the rat caudal IVD. Aim S2 studies will identify
changes in the molecular signatures of DRG populations and DRG sensitization with caudal IVD injury and anti-
inflammatory cell treatment. This project will stimulate substantial innovations on pain research approaches and
methodologies. Completion of this work will provide markers for new, functionally distinct sensory neurons
relevant to painful IVDs. The resulting catalog will also illustrate the diversity of sensory types and the cellular
complexity underlying painful sensation due to musculoskeletal degeneration, injury and treatment.

Public health relevance
Project Narrative Discogenic back pain, is a leading cause of disability, and involves degenerative changes of the intervertebral disc. Only a small subset of patients responds favorably to existing treatments, and there is a need for alternative options, including regenerative therapies. We are developing and optimizing use of anti-inflammatory cells for disc repair in hope that it improves outcomes for patients with back pain and degeneration.